Yale Center for Genome Analysis Shared Resource

YALE CENTER FOR GENOME ANALYSIS SHARED RESOURCE
PROJECT SUMMARY/ABSTRACT
The Yale Center for Genome Analysis (YCGA) was established in 2010 to provide next-generation sequencing
(NGS), single-cell genomics, and microarray support forYCC members. The Center is a full-service facility
dedicated to providing RNA expression profiling, DNA genotyping, and next-Gen DNA sequencing and related
state-of-the-art technologies. Full microarray and next-generation sequencing services provided by YCGA
include: DNA and RNA isolation from tissue and blood; sample preparation ready for microarray and next-Gen
sequence (NGS) analysis; providing primary data; full-time YCC-supported staff for downstream bioinformatics
data analysis, working collaboratively with YCC investigators and providing methods and other write-ups for
grants. Additionally, the staff has obtained equipment and center grants to reduce the cost of sequencing.
During the most recent funding period, 211 people have used YCGA Eighty-seven of these users (41%) were
YCC members. The majority of this use came from Genomics, Genetics and Epigenetics (GGE).
YCGA provides free consultation and training for YCC members. The core is led by Director Shrikant Mane,
PhD, Professor of Genetics, whose experience is complemented by the strong expertise of Associate Director
Kaya Bilguvar, MD, PhD.
The Specific Aims of YCGA are to provide: (1) Next-generation sequencing services using multiple sequencing
platforms, including Illumina, Ion Torrent, and Pacific Biosciences; (2) Microarray services using Affymetrix and
Illumina platforms for gene expression, genotyping, and methylation assays; (3) Single cell genomics and
structural variation determination using the 10X Genomics platform; (4) Research and development. YCGA
continuously carries out biotechnology research to develop improved methodologies and tools, to test the
relative merits of new technologies, and to generate preliminary results for NIH grants. (5) Bioinformatics. Dr.
Francesc Lopez supports the secondary analysis needs of YCC members. His salary is supported by YCC. (6)
Consultation. YCGA makes every effort to develop collaborative relationships with its users, and takes interest
in their scientific projects. (7) Education and training. Staff members actively participate in YCC Grand Rounds,
departmental seminars, and YSM Dean’s workshops aimed at providing principles and technical details of the
various genomic technologies.